Listening effort in cochlear implant users

Project summary / abstract
Listening to speech is more effortful for people with hearing loss than for those with normal hearing.
Individuals with hearing loss report greater amounts of fatigue, anxiety, and more sick-leave from work, and
social isolation. All of these factors impact quality of life for individuals, their friends and families. This project is
designed to better understand what makes speech perception more effortful than what would predicted by
common audiological measures like pure-tone thresholds and speech intelligibility scores. Specifically, we will
explore the mental cost of relying on context to figure out words, and whether that process gets disrupted by
the need to continue listening to upcoming sentences. We will also explore whether slower speaking rate
allows listeners to recover from mistakes in a timely fashion without missing the next sentence. These studies
will start with people who use cochlear implants, which are neural prosthetic devices that give auditory
sensation to people who have severe to profound hearing loss. We will quantify listening effort using time-
series measures of pupil dilation. These studies are intended to help understand listening effort and the
experience of hearing loss in ways that have not yet been revealed. After identifying particularly problematic
listening situations, we will expand the scope of work to include people with mild to moderate hearing loss in
similar experimental conditions.

Public health relevance
PROJECT NARRATIVE People with hearing impairment (including those with cochlear implants) exert extra effort to understand speech, and the resulting fatigue has dramatic economic, medical and social consequences. The goal of this project is to explore factors that make listening effortful, with special focus on the need to repair perceptual mistakes by relying on context.